In situ formed microneedle-like depots for spatiotemporally controlled drug delivery

PROJECT ABSTRACT
Conventional systemic drug delivery methods suffer from non-specific distribution, which can lead to reduced
efficacy, severe side effects, and the development of drug resistance. Drug-induced liver injury is the main cause
of acute liver failure, while drug-induced renal injury is the cause of around 20% of acute renal failure.
Antimicrobial resistance contributed to 4.95 million global deaths in 2019, while around 90% of metastatic cancer
patients experience resistance to chemotherapy. Localized delivery approaches have been implemented to
resolve these challenges. However, limited drug penetration, specifically for the treatment of biofilm infections,
results in poor outcomes. In the United States, more than 5 million patients suffer from superficial infections, with
an annual financial burden of ~$11-28 billion. Microneedle arrays (MNAs) can resolve the penetration issue in
localized drug delivery by bypassing the barriers against drug exposure to the cells and microbes. However,
“prefabricated” MNAs have limited translational capability due to poor tissue penetration, challenges associated
with their adaption to irregularly shaped large wounds, and limited compatibility with controlled spatiotemporal
distribution of different drugs. Furthermore, the limited number of needles in MNAs is insufficient to effectively
disrupt the biofilm and expose the microorganisms. We have recently developed a novel drug delivery strategy
based on intralesional printing of drug-eluting biomaterials depots to resolve these challenges of prefabricated
MNAs for drug delivery applications, and here we propose its evaluation in the treatment of wound infections.
Our hypothesis is that intralesional patterning of drug-eluting depots has a strong chance of treating various
defects including infected wounds through disruption of the physical barriers such as biofilms and delivery of
drugs with controlled spatiotemporal distribution. The ultimate goal of this proposal is to develop an intralesional
drug delivery strategy that enables maximum drug exposure to the target cells or microorganisms and enable
spatiotemporal control over drug distribution, with effectiveness in treatment of infected wounds. Our objective
is to in situ fabricate defect-specific and biodegradable gelatin-based drug depots carrying antimicrobial and pro-
regenerative drugs directly into the defect and compare their effectiveness with topical delivery for the treatment
of infected wounds. We will test our hypothesis in vitro, ex vivo, and in vivo, and achieve our objective through
the following specific aims: (1) characterization of the in situ formed microneedle-like drug depots and drug
release kinetics in vitro; (2) development and evaluating the effectiveness of sustained drug delivery from in situ
fabricated drug depots in the treatment of biofilms in an ex vivo porcine wound biofilm model; and (3) assessing
the effects of in situ fabricated drug depots on the healing of biofilm-challenged diabetic wounds in vivo.
Completion of this work will demonstrate the feasibility of the technology and enable us to evaluate its efficacy
in patient-derived microorganisms and pre-clinical large animal models of infected wounds in an R01 application.

Public health relevance
PROJECT NARRATIVE Current drug delivery methods are inefficacious and result in severe side effects and drug resistance, specifically for the treatment of infection. In this study, we develop, and test in infected wound models, a novel delivery method forming microneedle-like drug depots intralesionally to disrupt the biofilm and release antimicrobials and pro-regenerative factors in a controlled spatiotemporal manner. The delivered therapeutics are expected to minimize infection and enhance vascularization, thus contributing to enhanced rate and/or quality of wound healing.